Integrated Training For Physician-Scientists

PROJECT SUMMARY/ABSTRACT
The Medical Scientist Training Program (MSTP) at the University of Wisconsin-Madison (UW-Madison) aims to
train and prepare future leaders and physician-scientists in clinical medicine and biomedical research. Our
program trains diverse students across numerous fields, with a curriculum and training plan that is continuously
improved through metrics, critical self-assessment, and student input. Guiding principles of our program include:
(1) a rigor and caliber of both MD and PhD training equivalent to single-degree candidates; (2) continuous
mentoring from program leaders, faculty, and peers; and (3) training in translational research for all students.
The four program directors are all physician-scientists and each is active in research, graduate training, and
clinical activities. The student government works closely with the directors on recruitment, seminars, advising,
curriculum, and continuous improvement. Students begin with the preclinical phase of medical training, along
with a 3-semester MSTP-specific Integrated Molecular Medicine (IMM) course series, led by the directors. IMM
introduces new trainees to research methodologies, scientific writing, responsible conduct of research (RCR),
rigor, reproducibility and transparency (RRT), and implicit bias. Students then proceed through clinical clerkships
in the ForWard curriculum before beginning the Ph.D. thesis. Ph.D. mentor selection is made in consultation with
program leaders. Oversight of research rigor and Ph.D. mentorship is directly assured by an MSTP director on
each thesis committee. An integrated Longitudinal Clinical Experience spans the Ph.D. years. After defending
the Ph.D. thesis, trainees enter the final year of medical training, which includes the mentored Clinical &
Translational Research Elective (CTRE), custom-designed for MSTP trainees. CTRE is a 6-week preceptorship
with both clinical and research facets and an additional physician-scientist faculty mentor. The integrated
curriculum allows students to complete dual degree training in 7-8 years, with a minimal gap between intense
research activities and postgraduate training. A majority of student theses are in the biological, chemical,
population or engineering sciences, yet others select allied programs of study including anthropology, medical
history, and clinical investigation, a program integrated with our Clinical Translational Science Award (CTSA).
Additional activities foster program cohesiveness and encompass continuous training in RCR, RRT and implicit
bias via weekly seminars, our annual retreat and yearly symposium, and regular social gatherings. A diversity
committee, jointly led by students and faculty, directs activities for recruitment and retention of exceptional
trainees, including a new summer research program for underrepresented undergraduates, which will be
implemented in the grant period. RELEVANCE: Trainees receive integrated training in clinical medicine and
research and are awarded both M.D. and Ph.D. degrees. Through an innovative integrated physician-scientist
curriculum, the diverse graduates of our program are poised for research-intensive careers that integrate
rigorous basic and translational research and clinical care.

Public health relevance
PROJECT NARRATIVE The overall goal of the Medical Scientist (MD/PhD) Training Program (MSTP) at the University of Wisconsin- Madison (UW-Madison) is to train physician-scientists in the broad range of research areas critical to advancing frontiers of medical knowledge and therapeutics. Integrated MD/PhD programs, by immersing trainees in research during what are arguably their most impressionable and creative years, are a key component of our country’s portfolio to provide such training and dovetail into the combined missions of UW-Madison and its School of Medicine and Public Health (SMPH). UW-Madison consistently ranks as one of the top 20 research universities in the world and is especially well-known for graduate education and contributions to society. Research and education related to biomedicine are carried out in a large number of departments, centers, and programs inside and outside of the SMPH that are integrated, collaborative, and span the many disciplines that will improve the health of our nation and world.